Studies of Atomic Bomb Survivors

The Life Span Study (LSS) cohort of 94,000 survivors of the Hiroshima and Nagasaki atomic bombings is being studied in collaboration with the Radiation Effects Research Foundation (RERF). Cohort studies are used to quantify environmental radiation dose response and its dependence on histological subtype of tumor, age at exposure, sex, age at observation, time following exposure and other factors.More than half a century after the atomic bombings, a statistically significant excess risk of cancer is still apparent. The latest LSS solid cancer incidence report includes 17,448 first primary cancers among the LSS survivors, of which 853 are estimated to be excess cases attributable to radiation exposure. The shape of the dose response for solid cancers as a group and for many individual cancer sites continues to be well described by a linear model. The most important finding is that the excess absolute rates for solid cancer increase throughout life for all ages. The excess relative risks associated with radiation exposure are high for cancers of the bladder cancer, breast cancer and lung cancer, whereas excess absolute rates are high for stomach cancer, breast cancer, colon cancer and lung cancer. Solid cancer risks are especially high among these exposed in utero and early childhood. However, the uncertainty remains regarding the temporal patterns of the radiation-related cancer risk, especially among the survivor younger than 20 years of age at the time of the atomic bombings, and continued follow-up of this cohort is needed to clarify this uncertainty. A paper has been published on the long-term and temperal pattern of leukemia risk, demonstrating persistent increase of the risk 50 years after exposure.